Hepatic steatosis promotes liver metastasis

Project Summary/Abstract
Treatment of early stage breast cancer has substantially improved but preventing metastasis remains a more
elusive target. Obesity, which is endemic in our society, is associated with an increased risk of breast cancer
and accelerated metastasis. The means by which obesity compromises survival of breast cancer patients is,
however, poorly understood. Liver is among the most common sites of breast cancer metastasis and its
occurrence is generally associated with poor prognosis. Liver health is closely related to weight as obesity is the
major cause of fatty liver disease, estimated to be present in 1/4 to 1/3 of Americans.
We discovered that fatty liver disease markedly increases liver metastasis, in mice, by providing fuel to tumor
cells thereby accelerating their growth. Examination of human liver biopsies and MRI analysis suggests the same
is true in women with metastatic breast cancer. Thus, our first goal is to determine if treating fatty liver disease
reduces breast cancer liver metastasis and improves its response to chemotherapy. To identify potential new
treatments for liver metastasis we will explore the mechanisms by which fatty liver disease stimulates tumor
growth. Finally, we will ask if human breast cancers exhibit the same liver metastatic properties as those arising
in mice. If our conclusion proves true, treatment of breast cancer will universally require prevention and treatment
of fatty liver disease and therefore impact all affected women. Prevention and treatment of fatty liver disease in
breast cancer patients, however, may likely reduce liver metastasis and therefore prolong survival. Because fatty
liver disease is most often the product of obesity, educating patients about calorie intake, which can be instituted
immediately, may have significant effects on breast cancer prognosis.

Public health relevance
Project Narrative We have discovered that non-alcoholic fatty liver disease (NAFLD) promotes breast cancer liver metastasis, probably by providing hepatocyte-derived lipids as an energy source for tumor growth. Our goal is to determine if prevention of NAFLD retards liver metastasis and the mechanisms by which hepatocyte-derived lipids are transferred to tumor cells and promote their growth. If as our preliminary data suggest, our observations extend to patients, prevention and cure of NAFLD will be a priority in those with potentially metastatic cancer.